THICKNESS &TEXTURE DETERMINATION OF POROUS MATERIAL

The confocal and the SEM techniques win be used to investigate both the structure and the thickness of porous aluminum in order to determine its solid density and porosity.